Blood-Based Biomarkers for Personalized Risk Assessment of Breast and Ovarian Cancer

Project Summary
There remains a need to develop biomarker tests for personalized risk assessment of breast and ovarian
cancers. Such tests would not replace screening programs but would instead be a basic tool that can be
integrated with other risk models based on a subject’s characteristics to personalize the risk of harboring cancer
and inform on the need for screening and surveillance for earlier detection.
The primary translational objective of this proposal is to develop a multi-analyte blood-based
biomarker panel based on circulating proteins and autoantibodies against tumor antigens that inform about a
subject’s probability of harboring a breast or ovarian cancer. Studies by the applicant team have led to the
identification of a panel of cancer-relevant circulating proteins as well as autoantibodies against tumor proteins,
including TP53 and novel citrullinated antigens, for detection of breast and ovarian cancers. The PLCO cohort
is an excellent resource to further advance testing of candidate biomarkers and to also establish combination
rules together with subject characteristics for individualized risk assessment of breast and ovarian cancers to
optimized screening and surveillance for earlier detection of these diseases.
In Specific Aim 1, leveraging pre-diagnostic plasmas from 969 breast cancer cases and 106 ovarian cancer
cases as well as four times the number of non-case plasmas from female PLCO participants that did not develop
cancer during study follow-up, we will assess the time-dependent (e.g. 0-1 year, 1-2 years, etc) predictive
performance (AUC, sensitivity, specificity, positive predictive value (PPV), and negative predictive value (NPV))
of candidate biomarkers for detection of breast and ovarian cancers. Priority biomarker candidates will be
advanced to establish models together with pertinent patient characteristics (e.g. Gail Model for breast cancer)
for 1-year risk prediction of BrCa and OvCa. For modeling, we will adhere to the Predictability, Computability and
Stability framework. The entire PLCO specimen set will be divided into a Development Set and a Set-Aside Test
Set. Modeling and tuning of hyperparameters as well as initial validation will be performed in the Development
Set. The model with the best predictive performance (AUC) in the Development Set will be selected for
subsequent testing in the Set-Aside Test Set. In Specific Aim 2, we will leverage serial samples procured from
cases preceding a diagnosis of a BrCa or OvCa and serial samples for non-cases, and we will test
whether longitudinal trajectories of biomarker panel scores improve risk prediction. The proposed study
represents a validation of cancer-associated protein and autoantibody biomarkers and has high probability to
develop a blood test that can be implemented in the clinical setting for individualized risk assessment of breast
and ovarian cancers.

Public health relevance
Project Narrative The applicant group led by the Principal Investigator (PI) has conducted a series of Early Detection Research Network (EDRN) defined Phase 1-3 biomarker studies that have led to the identification and development of a panel of circulating proteins as well as autoantibodies directed against tumor proteins (including TP53 and novel citrullinated antigens) for detection of breast and ovarian cancers. The primary translational objective of this project is to advance candidate biomarkers for detection of breast and ovarian cancers via testing in pre- diagnostic plasmas from the Prostate Lung Colorectal and Ovarian (PLCO) cohort and to develop a multi-analyte blood-based biomarker panel based on protein and autoantibody biomarkers for risk assessment of breast and ovarian cancers. The resulting biomarker test would then be integrated with other risk models based on individual subject characteristics, such as the Gail Model for breast cancer, to deliver personalized cancer risk assessment and inform on a need for further pertinent tests that enable earlier diagnosis.